Selective Functionalization of Pyridines and Diazines via Heterocyclic Phosphonium Salts

Project Abstract.
The aim of this proposal is to develop a general process to functionalize pyridines and diazines so that
biologically active molecules can be accessed in an accelerated fashion. Pyridines are the second most common
nitrogen heterocycle observed in FDA approved drugs and related diazines (pyrimidines, pyrazines and
pyridazines) are also widely found. Traditional methods to functionalize these heterocycles are limited by
functional group tolerance, poor regiocontrol and lack of applicability to complex substrates. Our strategy to
functionalize these heterocycles will install a versatile functional group that enables a number of subsequent
bond-forming reactions. Specifically, we will transform pyridines and diazines into phosphonium salts and use
the unique reactivity of the phosphonium ion to make medicinally relevant derivatives. The 4-selective reaction
to make phosphonium salts will use common reagents, be trivial to perform and have a broad substrate scope.
We also propose to use this approach for late-stage functionalization of pharmaceuticals. Transforming
phosphonium salts into important pyridine and diazine derivatives will occur through distinct mechanistic
pathways. Direct reactions with nucleophiles will form C–C, C–O, C–S, C–N, and C–Hal bonds that occur via
SNAr processes or ligand coupling at the phosphorus center. Metal-catalyzed cross-coupling, using nickel and
cobalt catalysts, will be exploited for arylation and alkylation reactions. Base-mediated fragmentation reactions
form heteroaryl anions that will be used to install deuterium and tritium isotopes and form organometallics. A
conceptually new approach to make important bis-heterobiaryls will be developed base on phosphorus ligand
coupling processes. Collectively, this program will provide rapid access to pyridine and diazine derivatives that
have multiple applications in the pharmaceutical sciences. The long-term objective is for these methods to be
used as routine tools by medicinal chemists.

Public health relevance
Project Narrative. The aim of this project is to develop new chemical methods that will provide access to chemical motifs commonly found in small-molecule drugs. Specifically, pyridines and diazines are widespread components in therapeutic compounds and our proposed methods will directly transform these heterocycles into molecules of significance interest in medicinal chemistry. The methods will also be simple and practical and amenable to use by scientists in the pharmaceutical and biomedical sciences.